Neural Coding and Control of Pain Detection in Somatosensory Cortex

Summary/Abstract
We propose to: Aim 1) Deﬁne the temporal patterns and characterizing the LFP properties of S1 oscillations in
relation to pain in healthy and chronic pain conditions using novel behavioral assay; Aim 2) Correlate LFP
oscillations to underlying neural activity in S1 at the spiking level using NeuroPixels; Aim 3) Identify neural sub-
circuits in S1 using genetically-encoded voltage indicators during nociceptive behavior and investigate the
functional signiﬁcance of S1 neurons to nociceptive behavior. These aims will be achieved in mice using state-
of-the-art techniques for electrophysiological recordings of LFP and spiking activity in single units with
genetically-encoded voltage indicators in vivo combined with optogenetic interventions during sub-second
behavioral paradigms, therefore, this application will enhance our scientiﬁc understanding of pain mechanisms
in the brain and potentially lead to novel diagnostic and therapeutic approaches to better manage pain in the
clinical setting.

Public health relevance
Project Narrative This project proposes to investigate the correlation between brain rhythms and pain, and the causal mechanisms underlying these rhythms using novel behavioral models in rodents. Data generated from this proposal will enhance our understanding of the biomarker potential of brain rhythms for pain, and potentially identify targets for therapeutic interventions in chronic pain conditions.